Membrane-cloaked nanoparticles as mucosal vaccines against giardiasis

Project Summary
Giardia lamblia, a protozoan CDC category B priority pathogen, is an important cause of diarrheal disease
with hundreds of millions of annual cases worldwide. In the United States, G. lamblia is one of the two most
common causes of outbreaks of parasitic disease, with prevalence rates of 1-7%. Symptomatic giardiasis is
characterized by diarrhea, epigastric pain, nausea, vomiting, malabsorption and malnutrition, especially in
children. Long-term sequelae are common and can persist despite apparently successful treatment.
Importantly, infection can be initiated by ingestion of fewer than ten cysts, demonstrating that G. lamblia is
highly contagious and a credible threat to the safety of public water supplies and health. Trophozoites, the
disease-causing forms of the parasite, colonize the lumen of the small intestine and attach to the epithelium.
Infection is typically self-limiting, indicating that effective immune defenses exist. Despite the clinical
importance of G. lamblia, no preventive medical strategies are available. Prior preclinical studies have shown
that immunization with individual surface antigens can confer partial protection against G. lamblia infection in
mice and gerbils, but protection is not as effective as prior infection with the parasite, suggesting that single
antigens may not be sufficient to induce optimal protection. Multi-antigen immunizations can be done with live
pathogen vaccines, but the necessary attenuation has not been achieved for G. lamblia and may not be
possible due to the predictably compromised ability to colonize the intestine. As an alternative, we propose a
nanoparticle-based vaccine, constructed from the membranes of G. lamblia strains, which enables effective
multi-antigen mucosal immunization without concerns about adverse effects due to live microbe exposure.
The resulting nanoparticle vaccines offer several distinct advantages: i) delivery of multi-antigenic material
present on the pathogen surface, ii) stability and homogeneous sizing for effective transport in vivo and
efficient uptake into antigen-presenting cells, and iii) tunable immunological biasing by loading the core with
suitable adjuvants for controlled release. Therefore, our overall objective is to develop G. lamblia membrane-
coated nanoparticles as a novel mucosal vaccination strategy against giardiasis. We will systematically
fabricate different nanovaccine formulations with native pathogen membranes and test them for
immunogenicity and protective capacity in relevant animal models of giardiasis. This project brings new ideas
and approaches from the field of nanotechnology to the prevention of giardiasis, a highly contagious and
clinically important but largely neglected diarrheal disease. Importantly, our innovative strategy overcomes the
challenges associated with identifying single protective antigens or with using non-native, chemically modified
forms of the target pathogen, thereby greatly improving induction of adaptive immunity to multiple native
proteins found on the live parasite surface. The new strategy has broad implications for vaccine design for
other mucosal pathogens, including not only protozoan, but also bacterial and viral agents.

Public health relevance
Project Narrative The CDC category B priority pathogen Giardia lamblia is a leading cause of intestinal infection and diarrheal disease in the world, yet no preventive medical strategies exist. This exploratory project will develop nanoparticles coated with membranes of the pathogen as a novel mucosal vaccination strategy against giardiasis. The studies are highly innovative as they promise to bring new ideas and approaches from the field of nanotechnology to the prevention of giardiasis, a highly contagious and clinically important but largely neglected diarrheal disease.